GDA AFRPS Maintenance and Mutual Reliance Tracks FY26-28

Georgia Department of Agriculture
Project Title: GDA AFRPS Maintenance and Mutual Reliance Tracks FY26-28
Project Period: August 1, 2025 – June 30, 2028
Overall Summary
The Georgia Department of Agriculture (GDA) plans to utilize both the Animal Feed Regulatory
Program Standards (AFRPS) and Mutual Reliance Track to establish a uniform regulatory
foundation and opportunity to strengthen partnerships with the U.S. Food and Drug
Administration (FDA), as well as with other state animal food regulatory partners, to advance
food safety through collaborative efforts based upon mutual reliance and shared responsibility.
The overall objectives of this project are to ensure the AFRPS are maintained while conducting
regulatory work and promoting compliance with applicable federal and state regulations, as well
as utilizing data obtained through mutual reliance to reduce risk factors contributing to illnesses
in animals and humans. These objectives apply to firms that manufacture, process, pack, or
hold animal food products in the State of Georgia.
Additional objectives for this cooperative agreement include, but are not limited to, the following:
a) fully maintain the implementation of the AFRPS; b) enhance collaboration and information
sharing between FDA and state regulatory partners through the Integrated Food Safety System
(IFSS) through risk-based work, work sharing, and data exchange; c) reduce risk factors known
to contribute to illnesses in animals and humans, work with FDA and other state regulatory
partners for the early detection of animal food safety issues, and promptly investigate any
animal food related event likely to cause Serious Adverse Health Consequences or Death to
Humans or Animals (SAHCODHA); d) advance the GDA’s animal food audit program from
Phase II to Phase III within the three-year duration of this project; e) demonstrate the ability to
fully participate in initiatives supporting the AFRPS, such as annual face-to-face meetings,
quarterly meetings with FDA, verification audits, conference calls, and trainings; f) perform
comprehensive non-contract animal food inspections according to the CPGM 7371.000 and
perform said inspections under GDA’s authority, procedures, and policies; g) provide a properly
detailed budget for both the Maintenance and Mutual Reliance Tracks; h) participate in LFFM
sampling and acting on violative sample results by sharing data with FDA; i) developing an
outreach plan and associated materials related to the PCAF regulation and FSMA related rules
as part of GDA’s overall outreach plan; and j) demonstrate the availability of adequately trained
staff to meet the goals of the cooperative agreement.
Through collaborative work planning and data sharing between the GDA and the FDA, both
agencies aim to increase regulatory oversight of animal food activities throughout the state.

Public health relevance
Overall Project Narrative The mission of the Georgia Department of Agriculture (GDA) is to protect consumers, promote agriculture both locally and globally, and assist our customers using education, technology, and a professional workforce. The GDA will use the Mutual Reliance Track and Animal Feed Regulatory Program Standards (AFRPS) Maintenance Phase Track funding options to reduce risk-factors that are known to cause or contribute to animal and human illness through enhancement of collaboration efforts with the U.S. Food and Drug Administration (FDA) and maintaining full implementation of the AFRPS. With these funds, the GDA will improve its ability to advance animal food safety and protect public health.